REGULATORY ROLE OF HEPARAN SULFATE EMBRYONIC STEM CELL BIOLOGY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Heparan sulfate is abundant on the cell surface of undifferentiated and differentiating embryonic stem cells, but the role of heparan sulfate in stem cell biology is still largely unknown.